Utilizing Non-Functionalized Terpenes to Develop Novel Strategies and Chemoselective Transformations

PROJECT SUMMARY/ABSTRACT
As a class, terpene-based natural products have long led to critical scientific discoveries and advances.
For instance, the particular connectivity of longifolene served as the inaugural ground upon which to establish
the power of retrosynthetic analysis, while larger molecules such as steroids have been valuable tools to treat
and understand disease as well as a scaffold upon which to develop powerful bond-forming reactions such as
electrophile-induced polyene cyclizations and site-specific functionalizations. We believe that numerous
opportunities remain for further development within the class, and here we seek specifically to probe the
potential of structurally complex, but relatively non-functionalized, members to contribute to the development of
new reactions, strategies, and tactics of broad applicability. Our goal is to develop the means to both tailor and
deliver molecular structure with high specificity, mirroring chemistry that Nature can accomplish enzymatically
as well as contributing new reactions and tools that have no biological counterpart.
As delineated within the proposal, we seek to explore several avenues for possible advances. First,
drawing from a previously accomplished total synthesis of a strained molecule known as presilphiperfolan-8-ol,
we have designed an array of Pd-based Heck relay cascades, in a variety of different formats, to generate a
key patterning of atoms that is seemingly conserved across several different molecular collections despite
having distinct plant, and likely biogenetic, origins. Key goals for the present study are to affect such reactions
in contexts where competing β-hydride elimination pathways could preclude success, and to probe the viability
of Heck-type processes in highly hindered settings, such as ones that would utilize tetrasubstituted olefins as
acceptors. Second, we seek to utilize C-PdII intermediates in unprecedented trappings with intermolecular
oxygen and nitrogen nucleophiles to access highly regio- and enantioselectively functionalized gem-dimethyl
moieties. Finally, careful consideration of both how to synthesize and use quaternary centers has afforded
what we believe to be critical insights pertinent to synthetic design. This concept is illustrated by the proposed
generation of two different families of natural products in syntheses which either would be the only available
route to date or which are marked improvements on past efforts in terms of overall step economy.

Public health relevance
PROJECT NARRATIVE Efforts to synthesize unique terpene-based natural products in the laboratory have long served to advance the power and efficiency of available synthetic strategies and methods. This proposal seeks to further expand that toolbox by using the challenging connectivities and architectures of several relatively non-functionalized terpenes as inspiration to develop powerful C–C bond forming reaction cascades, site-specific functionalizations to incorporate heteroatoms on carbogenic frameworks, and new strategies for the utilization and generation of quaternary centers.